Senescent stromal cells drive chemotherapy-induced peripheral neuropathy

Chemotherapy has extended survival for cancer patients across the cancer landscape. Unfortunately,
chemotherapy is not benign as it induces a broad range of side effects that can significantly impact a cancer
survivor’s quality of life. One such side effect is chemotherapy induced peripheral neuropathy (CIPN),
affecting up to 90% of patients receiving taxanes, with 30% experiencing lifelong symptoms. Permanent
symptoms can include tactile or thermal allodynia (pain), numbness, and dysesthesia (tingling) in the hands
and feet, making everyday tasks a struggle. Current treatments, such as cryotherapy, offer only temporary
and limited relief. Because chemotherapy induces robust senescence, we asked if senescence contributed
to CIPN. Our genetic and pharmacologic studies revealed that senescence not only drives CIPN but also
hinders axonal repair post-chemotherapy. Here we will ask how senescence drives CIPN by, 1) elucidating
the impact of senescence on axonal loss in CIPN and 2) identifying senescent cells and determining how they
contribute to CIPN. Preliminary data suggest that senescent nonneuronal cells in the peripheral nervous
system (PNS) are key players in CIPN, likely through the secretion of p38MAPK-MK2 dependent senescence
associated secretory phenotype (SASP) factors that activate neuronal SARM1 and impede the formation of
reparative Schwann cells. We will use innovative genetic mouse models and in vitro assays to study the role
senescent cells play and elucidate their mechanisms of action in CIPN. Our work promises not only a deeper
understanding of CIPN’s molecular drivers but also potential new avenues for relieving the suffering of millions
of cancer survivors.

Public health relevance
NARRATIVE The development of chemotherapy-induced neuropathy (CIPN) is a diabilitatiing side effect of treatment that impacts upwards of 70% of all patients receiving chemotherapy and approximately 30% of patients will live out the rest of their lives with it. Most patients experience numbness or stabbing pain that can be so severe that basic life tasks can become a challenge and to date there are no treatments for this terrible “side effect”. We find that the elimination of senescent cells can rescue CIPN and here we will discover how senescent cells drive the development of CIPN and use that information to strategize treatments for patients suffer from CIPN.